The influence of 3D printed prostheses on neural activation patterns of the primary motor cortex in children with unilateral congenital upper-limb reductions

In the United States, more than 541,000 individuals live with congenital upper-limb reductions or amputations.
Worldwide estimates for upper-limb congenital reductions range from 4-5/10,000 to 1/100 live births. The use of
body-powered upper-limb prostheses helps children with upper-limb reductions to engage in functional activities
that are fundamental to normal growth and motor development. However, the development of prostheses for
children is complex due to their rapid and continuous growth. Up to 58% of children with upper-limb reductions
reject or abandon their prosthesis due to excessive weight, lack of visual appeal, limited function and complexity
of control. 3D printed prostheses provide a cost-effective solution to the development of light-weight, customized
and visually appealing prostheses for children, potentially encouraging use. Theoretically, the use of a prosthesis
may lead to an enlargement of the primary neuronal networks located in the cortical area involved with motor
control of the affected limb. Ultimately, this might lead to a larger repertoire of motor strategies and integration
of the prosthesis into the motor control of the child facilitating prosthesis acceptance. However, there is little or
no evidence supporting this hypothesis. The neural basis underlying motor performance in children using a
prosthesis has been severely understudied resulting in minimal empirical evidence. This is largely due to i) the
high prosthesis rejection rate and abandonment observed in this pediatric population making it difficult to properly
monitor behavioral or neural changes before and after using a prosthesis, and ii) technological constraints of
traditional neuroimaging techniques, such as functional magnetic resonance imaging (fMRI) and
electroencephalography (EEG), in the assessment of brain function of pediatric populations. Functional near-
infrared spectroscopy (fNIRS) has emerged as a practical neuroimaging technique that is less sensitive to noise
and movement artifacts than EEG and fMRI, making it easier for children to tolerate testing. The use of fNIRS in
conjunction with customized and visually appealing 3D printed prostheses would provide the unique opportunity
to quantitatively assess the influence of upper-limb prostheses in the neural activation patterns of the primary
motor cortex and motor performance of children. Our pilot work has shown a reduction of cortical activation, a
more efficient motor response, and increased coordination after prolonged use of a 3D printed upper-limb
prosthesis. This study will determine the influence of using a prosthesis on the neural activation patterns of the
primary motor cortex in children with unilateral congenital partial hand reductions. The central hypothesis is that
prolonged prosthesis use will result in a reduced primary cortex activation indicating that wearing a prosthesis
may assist the primary motor cortex to produce a more refined, specialized, and efficient motor cortex response
improving motor performance and the functional use of the prosthesis.

Public health relevance
The neural basis underlying motor performance in children using a prosthesis has been severely understudied resulting in minimal empirical evidence. The use of functional near-infrared spectroscopy (fNIRS) in conjunction with customized and visually appealing 3D printed prostheses would provide the unique opportunity to quantitatively assess the influence of upper-limb prostheses in the neural activation patterns of the primary motor cortex and motor performance of children. This information would increase our limited knowledge of how prosthesis usage influences the primary motor cortex of growing children and use this information to develop rehabilitation programs aimed at reducing prosthesis rejection and abandonment.